The role of catecholamines in immunotoxicity and tumor response of adoptive T cell therapy in cancer

Glioblastoma (GBM) is the most common primary brain tumor, and among the most lethal human cancers. No
cure exists, and only limited treatment advances have been achieved. A highly promising area of
immunotherapy is adoptive transfer of genetically engineered, patient-derived blood lymphocytes transfected
with chimeric antigen receptor genes (CARs) to target and destroy cancer cells, currently being explored for
treating GBM. Critical challenges to using CAR-modified T (CART) cells involve dose-limiting immunotoxicities
including cytokine-release-syndrome (CRS) and neurological toxicities. Most research has aimed at improving
CART efficacy, while the mechanisms of toxicities/adverse reactions, innovative strategies for their
management, and their implications for anti-tumor efficacy remain under-explored. I recently discovered that
endogenous catecholamines drive CART-induced CRS, via a self-amplifying feed-forward loop in immune
cells, and that inhibiting their production protected CART-treated Raji lymphoma-bearing xenograft mice from
lethal CRS and enhanced tumor eradication, suggesting separate pathways of immunotoxicity and anti-tumor
response. The goal of this proposal is to elucidate the mechanism by which catecholamines mediate
immunotoxicity in CART therapy in brain tumors and other cancers and assess their impact on the anti-tumor
response in immunocompetent cancer models. My central hypothesis is that catecholamines promote CART-
induced CRS and that its pharmacologic inhibition improves CART therapy safety and tumor-specific killing. I
will test this idea in 3 Specific Aims: 1) Evaluate the induction of catecholamines and CRS in an
immunocompetent CD19+ B cell ALL CART19 model, and determine the dual impact of suppressing
catecholamine production on cytokine release and anti-tumor responses, by analyzing catecholamine and
cytokine release in a CD19+ B cell ALL CART19 model, which recapitulates the CRS seen in human CART19
therapy; 2) Determine the signaling pathway by which catecholamines upregulate catecholamine production
and cytokine release in mouse CART19 (mCART19) therapy and how this affects CART functionality, by using
gene expression microarray and pathway reporter arrays to discover contributing mechanisms of epinephrine-
induced catecholamine and cytokine synthesis and by determining the effects of cytokines most significantly
altered on mCART19 cell activation, expansion and cytotoxicity; 3) Determine whether blocking endogenous
catecholamine synthesis reduces CART-induced systemic and CNS immunotoxicity and improves anti-tumor
responses in an immunocompetent mouse GBM model. The results will advance basic understanding of
endogenous pathways contributing to immunotoxicity, and may enable improved outcomes of CART therapy
and management of adverse immunotoxicities, via new insights into their mechanisms and a novel treatment
strategy of catecholamine blockade, which inhibits multiple cytokines more broadly than anti-IL6R antibody
(tocilizumab).

Public health relevance
Project Narrative Adoptive transfer of T cells genetically engineered with chimeric antigen receptors (CART) targeting cancer cells is a promising and rapidly developing treatment of various cancers including glioblastoma, which often encounter dose-limiting toxicities, such as cytokine-release-syndrome (CRS) and neurological toxicities. I recently identified that catecholamines drive CART-induced CRS via a self-amplifying loop in immune cells and that pharmacologic inhibition of catecholamine synthesis not only protected CART-treated xenograft mice from CRS, but also enhanced the tumor eradication by CART. This proposal aims to uncover catecholamine- mediated pathways contributing to immunotoxicity and its impact on the anti-tumor response.